UCSF Research in Alzheimer’s Disease and Dementia (RADD)

PROJECT SUMMARY/ABSTRACT
UCSF Research in Alzheimer’s Disease and Dementia (RADD) Summer Intern Program, developed and led by
the Science & Health Education Partnership (SEP) at UC San Francisco (UCSF), will annually support five
public high school students from backgrounds underrepresented in the biomedical sciences in research
internships. Students will intern in labs that seek to deepen our understanding of Alzheimer’s Disease and
related dementias with the goal of improving and developing treatments and preventative care to lessen the
burden of these diseases. The UCSF Memory and Aging Center (an NIA-designated Alzheimer’s Disease
Research Center), UCSF Institute for Neurogenerative Diseases, and the UCSF Center for Aging in Diverse
Communities (an NIA-supported Research Center for Minority Aging Research) work to translate research
science into improved diagnosis and care for people with dementia due to Alzheimer’s disease and related
diseases, as well as to find a treatment or prevention. These labs offer an ideal backdrop to develop interns’
ability to conduct rigorous scientific research. The specific aims for this project are to 1) develop students’
science skills, 2) build students’ awareness of AD/ADRD research and the biomedical careers available in the
field while also building their identities as researchers, and 3) foster college readiness.
This project leverages UCSF SEP’s experience coupling authentic research experiences with co-curricular
supports to prepare students to matriculate to and thrive in college, ultimately to increase participation in
AD/ADRD careers among students from backgrounds defined by the NIH as underrepresented in biomedical
research. The short- and long-term impacts of RADD on its student cohort will be documented through surveys
to track high school graduation, college matriculation, major selection and degree completion, as well as
students’ self-reported gains in science confidence, researcher identity, and belonging in science. Over the
lifetime of the project, 25 students will be engaged in authentic Alzheimer’s and related dementias research
projects and have the chance to leverage the support structures within RADD to propel themselves into a
science careers.

Public health relevance
PROJECT NARRATIVE Through UCSF Research in Alzheimer’s Disease and Dementia (RADD) Summer Intern Program, high school students from backgrounds underrepresented in the sciences will further their educational and scientific careers, while deepening their knowledge and understanding of cutting-edge research related to Alzheimer’s Disease and related dementias. This project will also help research scientists learn how to mentor students from backgrounds different from their own; thereby equipping these researchers to be more effective mentors throughout their careers. Ultimately, these efforts will help diversify the health science field, which has been repeatedly cited as a mechanism for addressing disparities in health and healthcare.